PEDIATRIC HYDROXYUREA STUDY IN SICKLE CELL DISEASE

The purpose of this study is to determine: 1) If hydroxyurea is effective in increasing the level of fetal hemoglobin in children with sickle cell disease, 2) If there are serious toxicities (side effects) in children treated with this drug and, 3) If hydroxyurea will effect growth.